Commercialization Readiness of Wearable Optically Pumped Magnetoencephalography

Abstract
Magnetoencephalography (MEG) has established itself as an indispensable tool for functional
brain imaging, offering unparalleled spatial and temporal resolution while being non-invasive.
Despite its advantages, current MEG systems based on superconducting quantum interference
devices (SQUIDs) are cost-prohibitive and lack adaptability, particularly for pediatric
populations. This project focuses on the development of a wearable MEG system based on
Optically Pumped Magnetometer (OPM) technology, a novel alternative to traditional SQUID
magnetometers. This innovation eliminates the need for cryogenic cooling, thereby overcoming
significant limitations associated with traditional MEG systems.
Using OPMs has enabled the development of a cost-effective, flexible, and high-resolution MEG
system (OPM-MEG). Our technology aims to match the spatial resolution of invasive techniques
such as Electrocorticography (ECoG), while maintaining the non-invasive nature of traditional
MEG. Additionally, it features a flexible helmet, accommodating individuals of all ages and
allowing for head movement during scanning—an important advancement in neuroimaging
technologies. Building on our successful Phase IIB project, where we developed and deployed
prototype high-density OPM-MEG systems in leading neuroscience laboratories, the current
project aims to finalize the essential steps for the commercialization of this groundbreaking
technology.

Public health relevance
Project Narrative By making OPM-MEG technology widely accessible, this project has the potential to revolutionize functional neuroimaging and significantly contribute to the advancement of neurological disorder diagnosis and research on a global scale. This could improve the prognosis for millions of patients suffering from a wide range of neurological conditions.